Development of a Biomimetic Stentless Pulmonary Heart Valve for the Treatment of Pediatric Congenital Heart Disease

PROJECT SUMMARY
Congenital heart disease (CHD) is caused by defects in the heart structure that occur at birth and affect blood
flow through the heart and the rest of the body. CHD affects around 10 out of 1,000 live-born children, 25% of
which will need an intervention or surgery within their first year of life. Circa 1 million children and 1.4 million
adults live with CHD in the US, and over 182,000 heart valve replacements are performed every year. Currently,
available heart valve prostheses do not perform as native cardiac tissue and have several limitations related to
their durability and ability to support tissue regeneration. In addition, they have been associated with
complications such as clots, increased risk of thrombosis and thromboembolism, calcification, and infection.
Replacement of bioprosthetic valves often requires complex and high-risk operations and poses an economic
burden of $1.7B in the US per year to the healthcare system.
Neoolife aims to overcome these major drawbacks in CHD therapy by developing tissue engineered heart
valves (TEHVs) that are fabricated using scaffolds that mimic human tissue. Through endogenous tissue growth,
Neoolife’s biomimetic pulmonary heart valves are extensively augmented or eventually replaced, leaving
autologous and functional leaflets that grow with the CHD pediatric patient that are durable and non-
thrombogenic. These biomimetic valves do not require life-long blood thinner treatments and are resistant to
calcification and infection. In this STTR Phase I project, Neoolife will modify its proprietary Double Component
Deposition (DCD) technology to obtain a more homogeneous biomimetic scaffold deposition. Biomimetic
pulmonary heart valve prototypes (n=10) will be fabricated using a new multiple stage processing setup. The
prototypes will be tested in vitro for their mechanical and functional properties and assessed in vivo (n=5, 180
days) to evaluate polymer degradation, cellularization, biomechanics, and valve function.
In Phase II, further in vitro and in vivo studies will be performed to provide sufficient technical information to
demonstrate that Neoolife developed pulmonary heart valve qualifies for obtaining a Humanitarian Device
Exemption (HDE) designation for the treatment of pediatric CHD.

Public health relevance
PROJECT NARRATIVE Congenital heart disease (CHD) is the most frequent birth defect that comes with a high risk of requiring life- saving surgery within the first year of the newborn’s life. The most common procedure for CHD is pulmonary heart valve replacement, but current valve solutions are inadequate with over 20% of cases needing reoperations within 5 to 15 years of implant. This STTR project will address the limitations of current bioprosthetic valves by developing a biomimetic pulmonary heart valve that successfully mimics human tissue, which will increase the quality of life and decrease the risk of reoperations for pediatric CHD patients.